Senior Leaders

The Senior Leaders of the UC Davis Cancer Center are Ralph de Vere White, M.D., Director; Hsing-Jlen Kung, Ph.D., Associate Director for Basic Science; David R. Gandara, M.D., Associate Director for Clinical Research; Moon Chen, Ph.D., M.P.H., Associate Director for Cancer Control; Dennis Matthews, Ph.D., Associate Director for Biomedical Technology; Primo Lara, M.D., Associate Director for Translational Research; Jeanine Stiles, Associate Director for Administration; and, Ken Turteltaub, Ph.D., Senior LLNL Liaison.